Orthotic Treatment of Diabetic Foot Ulcers: Patient Adherence to Prescribed Wear and Effectiveness of Treatment

Patients who present to Podiatry with a diabetic foot ulcer are prescribed orthoses to offload and protect the
foot from further damage. However, the available anecdotal and scholarly data suggests that patients do not wear
orthoses as prescribed. There are often negative health consequences when these orthoses are not worn and
added costs to the healthcare system associated with the negative health outcomes.
The goal of this work is to encourage the use of orthoses by diabetic foot ulcer patients. The diabetic foot ulcer
patient’s participating in this study will have their orthosis wear-time measured between clinic visits. The use of
the orthosis will be encouraged in one group using education and motivational interviewing. Measured wear time
will also be discussed with this group of patients. The second group of patients will not be actively encouraged to
wear the orthosis. Routine clinical data will be collected in tandem with wear-time data in both groups.
These data will be used to objectively determine how often patients wear their orthosis, whether active
intervention can modulate orthosis wear time, and provide an objective measure of the effectiveness of orthosis
use. The goal of the study is to improve outcomes for Veterans treated in the VA for diabetic foot ulcers, reduce
complication rates from non-use of orthoses and to, thereby, reduce healthcare costs.

Public health relevance
The United States Department of Veterans Affairs spends an estimated $1.5 billion a year on healthcare for patients with diabetes. The prevalence and complications of diabetes increase with age. Therefore, with the aging of the US and Veteran populations, there is an expectation of increased healthcare costs associated with treating diabetes and the associated complications of this disorder. One common complication is the diabetic foot ulcer. Diabetic foot ulcers are expensive to treat, can take a long time to heal and result in a decrease in patient quality of life. Patients remain susceptible to developing more foot ulcers over time. The goal of this project is to reduce the time it takes to heal a diabetic foot ulcer, increase the time between episodes of ulceration and improve the quality of life for diabetic foot ulcer patients.